Impact of HIV and antiretroviral initiation on skeletal biology

ABSTRACT
Osteoporosis and fractures are known complications of HIV and antiretroviral therapy (ART). Bone mineral
density (BMD) decreases 2-4% within the first year after ART initiation and is worse with exposure to specific
ART such as tenofovir disoproxil fumarate (TDF). The mechanisms of HIV and ART associated bone loss are
still uncertain because tissue-level data are lacking. Through a collaboration between investigators at Columbia
University and University of São Paulo with complementary expertise in HIV and bone research, we were able
to perform the first comprehensive longitudinal bone biopsy study in ART-naïve young men before and 12 months
after initiation of TDF/lamivudine/efavirenz. We found evidence of bone formation and mineralization
abnormalities before ART. After ART, there was an increase in bone cellularity, but a persistence in bone
mineralization defects. Our goal is to enroll adult ART-naïve men and women with HIV (n=30) who are initiating
abacavir/lamivudine/dolutegravir an ART regimen that is not associated with bone loss, in a comprehensive
longitudinal study to compare the skeletal effects of the two ART regimens. We will evaluate bone density and
strength using dual energy Xray absorptiometry (DXA) and High Resolution peripheral Quantitative CT
(HRpQCT) with finite element analysis (Aim 1), obtain paired iliac-crest bone biopsies to evaluate
histomorphometry and tissue-level mechanical properties using nanoindentation/ramen spectroscopy (Aim 2),
and perform bone cell transcriptomics to explore underpinning molecular pathways. These studies are critical for
development of safer ART options for long-term use in children with HIV to attain peak bone mass and in older
adults with HIV to prevent fracture. This proposal leverages state-of-the art bone research techniques in a
multidisciplinary collaboration of HIV and bone researchers from the U.S. and Brazil and provide opportunities
for training to augment the bone research capacity at the University of São Paulo.

Public health relevance
PROJECT NARRATIVE Osteoporosis and fractures are recognized complications of HIV and antiretroviral therapy. We will use advanced bone imaging and bone biopsies assays to compare bone structure and quality after starting two different common antiretroviral regimens, and to determine the mechanisms of bone loss caused by antiretrovirals.